Linking endotype and phenotype to understand COPD heterogeneity via deep learning and network science

Summary/Abstract
Chronic obstructive pulmonary disease (COPD) is the 4th leading cause of death worldwide, resulting in an
immense public health burden. The clinical manifestations of COPD are extremely heterogeneous, and
disease course is affected by numerous endogenous and exogenous factors. Finding groups of patients with
similar pathobiology is crucial for the accurate prediction of disease progression and the development of
personalized treatments. Currently, clinical research has been divided in the discrimination of patients based
on either their phenotypic features, such as lung function, exacerbation frequency/intensity, presence of
emphysema (clinical subtyping), or on the molecular compositions of their biological samples, as assessed
through multi-omics assays (molecular subtyping). Despite providing some insights on different groupings of
COPD patients, little agreement has been found between these two classification approaches. As such, the
connection between pathophysiological processes, exposures, and their phenotypic consequences is currently
unclear. In this application we propose to use deep neural network architectures to integrate phenotypic and
genomic data of COPD subjects and construct integrated patient profiles that describe both the phenotypic and
molecular features of the patient simultaneously. These profiles will be used to cluster patients to find joint
clinical and molecular subtypes (endotypes) for COPD and to predict disease outcomes across a 5-year time
span. We will extract the characteristic clinical and molecular features of each endotype to obtain endotype-
specific biomarkers and connect them to clinical manifestations of COPD. Finally, we will develop network-
based approaches to understand the key molecular pathways and regulators associated with each endotype.
Achieving the objectives proposed in this plan will require a unique set of skills that span biology, network
science, machine learning, and lung disease biology. Although Dr. Maiorino’s past career trajectory has
prepared him well for the proposed research, advancing our current understanding of COPD heterogeneity is a
challenging task that will require further training in specific areas. Dr. Maiorino has developed a comprehensive
training program focusing on pulmonary disease biology, omics data integration, and high-dimensional
statistics. Dr. Maiorino will take advantage of the rich intellectual environment offered by the Channing Division
of Network Medicine and Harvard Medical School to attend courses and participate in regular meetings with his
mentors and advisory board members. Altogether, Dr. Maiorino’s training and research plan will enable him to
expand his current skillset and to develop into an independent investigator contributing to the advancement of
precision medicine in COPD.

Public health relevance
Project Narrative In this application, we propose to use machine learning to construct COPD patient profiles integrating their clinical and genomic data to study COPD heterogeneity. We leverage these integrated profiles to identify biologically meaningful COPD subtypes and predict disease outcomes. Finally, we use network-based methodologies to identify the biological pathways connected to each subtype and gain a deeper understanding of the molecular underpinnings of COPD heterogeneity.